Red blood cell released ATP in disturbed blood flow-initiated site specific vascular inflammation and atherosclerosis

Vascular inflammation and atherosclerosis are implicated in many cardiovascular diseases. While the
systemic risk factors such as hyperlipidemia are exposed to entire vasculature under pathological
conditions, the atherosclerotic plaques often preferentially develop at sites with disturbed flow, indicating
a role of hemodynamic forces in atherogenesis. For decades, endothelial cell (EC) responses to the
changes in wall shear stress (WSS) have been the main, if not sole, focus of the flow dynamics related
studies, which basically consider the circulating blood as a cell-free fluid and completely overlooked the
impact of mechanical force-activated blood cells on the vascular walls. Our recent study conducted in intact
venules showed that changes in blood flow alter EC function through both WSS and the SS-induced
release of ATP from RBCs, and the RBC released ATP through a pannexin 1 (Panx1) channel plays a key
role in altering EC barrier integrity. This novel observation led us to hypothesize that the RBC-released
ATP during blood flow changes plays a significant role in site-specific vascular vulnerability and
synergistically contributes to the initiation and progression of vascular inflammation and
atherosclerosis along with local WSS and systemic risk factors. This hypothesis will be tested
experimentally in vivo and computationally in silico under three specific aims using two newly established
hypercholesterolemia mouse models with blood cell specific deletion of Panx1 (ApoE-/-Panx1-/- and AAV-
PCSK9DYPanx1-/- fed with high fat diet). Aim 1 is to investigate the role of RBC-released ATP in the site-
specific endothelium vulnerability to inflammation; Aim 2 is to investigate the contribution of RBC released
ATP to hypercholesterolemia-induced site-specific plaque formation and atherosclerosis progression in
major arteries. Our preliminary data showed about 40-60% reduction of aorta atherosclerotic plaque at
branch regions in mouse with RBC Panx1 deletion, suggesting an important role of RBC released ATP in
disturbed blood flow-initiated vascular pathogenesis. The potential roles of RBC released ATP in blood
immune cell alterations, plasma microparticles and cytokine levels will also be investigated. Aim 3 is to
utilize a high-fidelity, three-dimensional, multiscale computational model to predict the distribution of SS on
the RBC membrane, the stress-induced ATP release, and the distribution of ATP at the vascular walls.
Complementing the in vivo studies proposed in Aims 1 and 2, the proposed computational studies will
provide, for the first time, a distinction between the roles of RBC stress and WSS in both micro and macro-
circulation under diverse flow conditions, and hence, hemodynamic insights into RBC-mediated vascular
pathogenesis. The proposed study challenges the conventional views in the field and will provide a more
comprehensive characterization of local hemodynamic and systemic environmental factors responsible for
vascular pathogenesis and aid the development of novel therapeutics.

Public health relevance
Project Narrative In the presence of high risk factors in the circulation such as high cholesterol or metabolic diseases, lipid accumulation and inflammatory cells invasion often occur at vascular regions that have different blood flow patterns due to vascular geometric shape. Current studies have been focused on the pure fluid effect on those regions, and overlooked the effect of flow on blood cells, especially red blood cells (RBCs), the majority cells in the blood. The proposed studies will fill this gap and investigate how the blood flow changes affect RBCs and subsequently affect the vulnerability of vessel walls and promote inflammation and atherosclerosis.